Understanding Cardiovascular Disease Mechanisms

ABSTRACT
This is a first renewal application for a pre- and postdoctoral training program, the title and theme of which is
“Understanding Cardiovascular Disease Mechanisms”. The University of Cincinnati and Children’s Hospital
has a renowned legacy spanning more than 4 decades of previous NIH T32 support for cardiovascular study,
and this current T32 represents the only CV program in Cincinnati. Our collective 18 faculty in this renewal
have placed 238 of their past trainees into academics over their careers, 153 of whom have run, or currently
run independent research programs. In the past 4 years of this program, our 17 trainees published 43 papers
and 5 received independent grant funding during their support period, while 5 graduates have matriculated to
jobs in scientific careers. The overall scientific emphasis of our training program will continue to build from a
basic platform of cardiovascular physiology, cell biology, biochemistry and pharmacology, but will also
incorporate the latest approaches in biomedical research, as well as incorporating clinical and translational
approaches. The cardiovascular environment at Cincinnati Children’s and the University of Cincinnati is
considered one of the very best in the country. Our 18 TG faculty are all NIH funded (some 47 NIH funding
components amongst them as PI status), 165 collaborative papers published together, and they are employing
the very latest technologies and approaches with outstanding core support. The leadership consists of the co-
PIs Drs. Evangelia Kranias and Jeffery Molkentin, both of whom have a long track record of working together
(20 years), as well as having excellent mentorship credentials. The Executive Committee (2 members),
Internal Advisory Committee (4 members) and External Advisory Committee (3 members) are highly engaged
cardiovascular researchers who will continue to help ensure the quality of the training program. The renewal
requests continuation of the funding of 3 pre- and 3 postdoctoral trainee positions. Predocs are selected by the
Internal Advisory Committee from a vast and outstanding pool of candidates amongst 7 departmental graduate
programs, while postdoctoral candidates are selected based on being accepted into a mentor’s laboratory and
then passing the screening process by the Internal Advisory Committee and co-PIs. The mentoring program
and evaluation process for the program are highly structured and oversight occurs on many levels. Trainees
and mentors are evaluated every 6 months with IDPs processing. The proposed educational training
curriculum is highly structured and state-of-the-art. Recruitment of minorities has been successful in the past
with our faculty, and it will remain a top priority.

Public health relevance
PROJECT NARRATIVE Heart disease remains the leading cause of death and disability in the western world. This proposed renewal training grant application will again focus on this theme, and our collective 18 faculty members have made this their life’s work. The program will train the highest quality of young scientists in cardiovascular research, who will be the future leaders in developing better therapy and treatment for this devastating condition.